CORE--CYTOMETRY AND CELL PURIFICATION

SPECIFIC AIMS: 1) To make readily available flow cytometry, cell sorting, confocal image cytometry and laser capture microdissection instrumentation and techniques to research projects in the basic biology of aging. 2) To assist investigators in finding appropriate ways to apply these techniques to their research objectives. 3) To assist investigators in the application of computer software for flow and image cytometry data analysis and presentation, including customized software programming, as needed.